2024 Angiotensin Gordon Research Conference and Seminar

PROJECT SUMMARY
The 2024 GRC on Angiotensin will focus on the latest advances in the RAAS, from discovery science to
clinical impact. The highlight will be the interplay between RAAS and other hormonal systems and how
this influences interorgan communications from cell signaling to systems biology, and the implications
in drug discovery. We will discuss interactions between the RAAS and other hormonal and biological systems,
the mechanisms of systems crosstalk, and its effects on inter-organelle and inter-organ communications to reveal
the role of the RAAS across systems. Growing evidence indicates extensive communication between distant
organs in health and disease. Examples include axes between gut-brain, heart-kidneys, heart-brain, liver-heart,
adipose-vascular, and immune-cardiovascular. Preceding the GRC, is the 2024 Gordon Research Seminar
(GRS), a unique forum organized by junior investigators for graduate students, postdoctoral fellows, and early
career researchers, to present and exchange new data and cutting-edge ideas. The GRS will focus on sharing
knowledge of recent tools and breakthroughs to explore the RAAS system in the pathophysiology of
cardiovascular diseases. The mentoring block will emphasize career development and provide a session to
discuss important aspects such as grant writing and self-management. Moreover, it offers a one-to-one meeting
with a mentor to discuss career planning. Our scientific program is designed to attract a new broader community,
including scientists, clinical researchers, biomedical engineers, computational biologists, and data scientists from
across the world, and will facilitate opportunities for networking between diverse disciplines.
The theme of the GRC is ‘The Interplay Between the RAAS and Other Hormonal Systems: From Cell Signaling
to Novel Therapies,’ and the specific aims are to:
1. Highlight the interplay between the RAAS and other hormonal systems and how this influences interorgan
communications from cell signaling to systems biology and the implications in drug discovery.
2. Discuss the mechanisms of systems crosstalk and its effects on inter-organelle and interorgan
communications will reveal the role of the RAAS across systems. This is especially important because growing
evidence indicates extensive communication between distant organs in health and disease.
3. Foster mentoring and networking among trainees, women, under-represented minorities, undergraduate and
graduate students, postdoctoral fellows, early career scientists, and expert investigators in the RAAS field.
4. Facilitate career-planning for junior scientists and help successful development in basic, clinical, and
translational sciences in the RAAS field.

Public health relevance
PROJECT NARRATIVE The 2024 GRC on Angiotensin will focus on the latest advances in the renin-angiotensin-aldosterone system (RAAS), from discovery science to clinical impact. The highlight will be the interplay between RAAS and other hormonal systems, how this influences interorgan communications from cell signaling to systems biology, technological innovation and drug discovery.